Relative and synergistic contributions of PD1 and LAG3 on CD4+ T conventional cells in cancer

ABSTRACT
Cell surface inhibitory receptors (IRs) such as programmed cell-death-1 (PD1) and lymphocyte activation gene
3 (LAG3) are upregulated on activated and exhausted T cells (TEX). CD8+ TEX develop from chronic antigenic
stimulation and are defined by sustained multi-IR expression, impaired effector functions, poor proliferative
potential, transcriptional reprogramming, epigenetic scarring, and metabolic dysfunction. Immune checkpoint
blockade (ICB) immunotherapies target IRs such as PD1 aiming to reinvigorate CD8+ TEX function for improved
tumor clearance; however, many patients fail to respond. Our laboratory was the first to demonstrate that PD1
and LAG3 dual blockade was superior to PD1 alone in murine tumor models. PD1 and LAG3 are now major
therapeutic targets. However, little is known regarding mechanistic impact of anti-PD1/anti-LAG3 combinatorial
synergy. We recently reported that PD1/LAG3 synergize to drive CD8+ TEX in murine melanoma, and we reported
similar results clinically. However, the combined activity of PD1/LAG3 observed during global deletion and
monoclonal antibody-based approaches is not as robust following CD8+ T cell-specific deletion, suggesting
PD1/LAG3 effects other T cell types, such as CD4+ T cells. CD4+ T cells play crucial roles in cancer
immunotherapy by providing help to CD8+ TIL and exerting direct anti-tumor cytotoxic functions. On the other
hand, recent evidence suggests that CD4+ T cells can display an exhaustion-like profile, including expression of
PD1 and LAG3, that correlates with worse outcomes. Although there is growing evidence for CD4+ TEX in cancer,
little has been done to mechanistically dissect their phenotype, function, molecular profile, or regulatory
mechanisms to better understand their significance. While the role of PD1/LAG3 in CD8+ TEX is well established,
it remains unknown whether these IRs drive a similar state in CD4+ T cells within the tumor microenvironment
and how this might impact anti-tumor responses. My central hypothesis is that PD1 and LAG3 exert differential
yet synergistic effects on CD4+ T cells to drive their exhaustion and impaired anti-tumor responses. My overall
goal is to mechanistically dissect the cell-intrinsic effects of CD4+ Tconv-specific PD1/LAG3 loss and the cell-
extrinsic impact on CD8+ T cells to better understand CD4+ TEX and their impact on anti-tumor immunity. I will
perform adoptive transfers of melanoma tumor antigen-specific CD4+ T cells that lack PD1 and/or LAG3, and
assess phenotypic, functional, transcriptional, and epigenetic features of CD4+ tumor-infiltrating lymphocytes
(TIL) to determine the cell-intrinsic effects from PD1/LAG3 loss. I will compare our findings with our published
data on PD1/LAG3-deficient CD8+ T cells (Aim I). Then, I will assess the impact of CD4+ T cell-specific
PD1/LAG3 loss on CD8+ TEX by performing phenotypic, functional, and transcriptomic analyses of CD8+ TIL
following A.T. of PD1/LAG3-deficient CD4+ TIL (Aim II). Elucidating the cell-intrinsic and cell-extrinsic
contributions of PD1 and LAG3 on CD4+ T cells will improve our mechanistic understanding of CD4+ TEX and
their significance in anti-tumor immunity, which is crucial for the advancement of immunotherapies.

Public health relevance
PROJECT NARRATIVE Targeting the inhibitory receptors programmed cell-death-1 (PD1) and lymphocyte-activation gene-3 (LAG3) expressed on the surface of exhausted (dysfunctional) T cells have represented a significant advancement in cancer immunotherapy for melanoma, and this approach is being tested in a growing number of cancer types. However, it is unclear how targeting PD1 and LAG3 together leads to improved anti-tumor responses, and why not all patients respond. This proposal aims to determine how PD1 and LAG3 impact the function of CD4+ T cells, an immune cell important in anti-tumor responses, to advance our understanding of how blockade of these receptors might reinvigorate CD4+ T cell function with the hope to identify novel therapeutic targets to further improve outcomes.